Obesity Health Disparities Research PRIDE Program (OHD PRIDE)

ABSTRACT
Overweight and obesity directly contribute to cardiovascular risk factors for cardiometabolic multimorbidity (i.e.,
type 2 diabetes, hypertension, coronary heart disease, chronic kidney disease, and stroke) and can lead to the
development of cardiovascular disease independent of other cardiovascular risk factors. Recent projections
indicate that nearly half of all adults in the U.S. (48.9%) will be obese by 2030 and severe obesity will be the
most common body mass index (BMI) category among women, African Americans, and low-income adults.
Numerous reports have called for effective interventions for weight loss and weight management to slow and
ultimately reverse current trends. Evidence from leading scientific organizations suggests that advancing this
effort requires diversifying the biomedical research workforce with individuals from underrepresented groups
also most affected by the obesity epidemic. Increasing the size, skill, and diversity of the scientific workforce
calls for investment in training, and the National Heart, Lung, and Blood Institute (NHLBI) answers this call with
its signature initiative – Programs to Increase Diversity among Individuals Engaged in Health-Related
Research (PRIDE). Our site, Obesity Health Disparities (OHD PRIDE) joined the NHLBI PRIDE family in 2014
and has implemented and evaluated a comprehensive research training and mentoring program for early-
career faculty and transitioning postdoctoral fellows underrepresented in biomedical sciences. OHD PRIDE is
the only funded site focused on obesity research and the only program specifically designed for eligible faculty
employed at or who were trained at Minority Serving Institutions (MSIs). In this renewal proposal, we describe
our strategy for implementing and evaluating a refined evidence-based, culturally- and contextually driven
research training and mentoring program specifically designed for research-oriented, early-career faculty who
are employed and/or trained at MSIs. OHD PRIDE will consist of five phases: (1) an initial 10-day intensive
summer institute delivered in a phased, hybrid format; (2) longitudinal mentoring and networking during the
academic year, including Writing Accountability Groups (WAGs); (3) tailored mentor support to submit
competitive small research grant proposals (SRP); (4) a 3-day face-to-face mid-year meeting; and (5) a face-
to-face culminating summer institute that will emphasize completion of SRP manuscripts for journal
submission, career coaching, grant writing, and mock study sections. Our proposed program will draw from
lessons over the past nine years to continue training and mentoring in obesity health disparities research
across the life course, training in the responsible conduct of research, and secondary data analysis. OHD
PRIDE features a dedicated group of trained research mentors, career coaches, and researchers (many of
whom are faculty of color) with a strong track record of conducting a range of faculty development, research
training, and mentoring programs with diverse populations employed in MSIs and majority institutions.

Public health relevance
PROJECT NARRATIVE Obesity is a major public health problem that requires interdisciplinary and diverse teams to significantly reduce or eliminate its impact on cardiometabolic health outcomes. The OHD PRIDE research training and mentoring program is designed to provide comprehensive mentorship, education and networking opportunities in obesity health disparities research to early career faculty from underrepresented backgrounds. Mentees who are employed or who were trained at Minority Serving Institutions will participate in a two-year program intended to enhance their skills in research, grant writing, and scientific writing. The work of OHD PRIDE Program will contribute to the diversification of biomedical research by increasing the number of early faculty from underrepresented backgrounds who launch independent research careers focused on obesity disparities and related chronic diseases.